The Impact of HIV on the Tumor Microenviornment and Survival in Colorectal Cancer Patients in South Africa

PROJECT SUMMARY
People living with HIV (PWLH) now have improved access to highly effective anti-retroviral therapy (ART),
leading to an aging global population with HIV. This aging population is experiencing a higher incidence of chronic
and age-related diseases, including cancer. Non–AIDS-defining cancers are now the leading non-AIDS cause
of death in PLWH. Colorectal cancer (CRC) is the fourth most diagnosed cancer worldwide, and prevalence
among PLWH is increasing. Studies conducted in the US show that PLWH are less likely than others to receive
curative-intent cancer treatment for CRC and have worse cancer-specific and overall mortality, even when
accounting for treatment disparities. These findings suggest an underlying biological difference between
colorectal tumors that develop in people with and without HIV, but few studies have tested this hypothesis.
In the proposed study we will collaborate with investigators at the University of KwaZulu-Natal in KwaZulu-Natal,
South Africa, a province with a high HIV prevalence rate, especially in the Black African population (27.2% among
those ages 15-48 years). Using an existing database, we will conduct a retrospective review of patients with
(n=145) and without (n=290) HIV who were diagnosed with CRC in KwaZulu-Natal province between 2000-2020.
The goal of this study is to determine how the presentation of CRC differs in the population with and without HIV,
whether PLWH experience cancer-treatment disparities, and how overall and cancer-specific survival differs by
HIV status. This study will be one of the first to examine the effect of HIV on CRC in an HIV-endemic population.
Further, we will obtain pathology slides from patients with CRC with (n=25) and without (n=25) HIV who
completed curative-intent treatment for localized CRC and compare characteristics of the tumor
microenvironment (TME) by HIV status. Based on preliminary data in women with breast cancer with and without
HIV, we hypothesize that we will observe increased T-cell density in the TME of cancers from people with HIV,
compared to those without HIV, but that there will be increased markers of T-cell exhaustion. In future studies
we will examine whether differences in the TME may explain disparities in cancer-specific and overall survival
between people with and without HIV and CRC.

Public health relevance
PROJECT NARRATIVE We propose a study in collaboration with the University of KwaZulu-Natal in Durban, South Africa that will address several key knowledge gaps about the effect of HIV on colorectal cancer (CRC) pathogenesis, treatment, and outcomes in an HIV-endemic population. We will conduct a retrospective study to 1) compare overall and CRC- specific survival between patients with and without HIV diagnosed with CRC in South Africa and 2) compare aspects of the TME between CRC tumors from patients with and without HIV, using multiplex immunohistochemistry. The proposed work may reveal biological differences that are generalizable across cancer types and may represent unique therapeutic targets in people living with HIV and cancer.